Interdepartmental Neuroscience Program

Project Summary/Abstract
This proposal is for continued NIH support 0f graduate student training in the Interdepartmental Neuroscience
Program (INP) of Yale University. The INP is Yale’s university-wide interdepartmental doctoral program,
currently in its 32nd year. Currently six students are supported in years 1 and 2 (a total of 12 students annually)
by the INP Jointly Sponsored Predoctoral Training Program in Neuroscience (JSPTPN). As a reflection of the
notable increases in applications from TG-eligible students as well as the increase in Yale neuroscience
faculty, tuition and stipend support is requested for an additional seventh student for each year (a total of 14
students). The faculty of the INP’s T32 JSPTPN consists of 83 neuroscientists from the Arts and Sciences
(FAS) and the Yale Medical School (YMS). For the 2019/2020 academic year there are 82 predoctoral (NOT
including our 22 MD-PhD students working full time in lab) graduate students, of which 50 are TG-eligible. The
INP is directed by Charles Greer and Haig Keshishian and supervised by an executive committee
representing a cross-section of INP faculty and graduate student representatives. Greer and Keshishian
serve as the Program Directors for the INP’s T32 Training Program. The INP receives strong university
support, including salaried administrators, office space, 8 full fellowships with tuition, and stipend
supplementation. The doctoral program undergoes scheduled reviews by the Graduate School as well as our
own anonymous reviews from students and faculty and an outside advisory committee. The INP is part of
Biological and Biomedical Sciences (BBS) umbrella program, but students are admitted directly into the INP
through a neuroscience admissions committee. Upon affiliating with the INP the students remain in the
interdepartmental program through their graduation. On average over the past funding cycle, 171
US/permanent resident students have applied annually, with 32% offered admission, for an entering class
averaging 11 students (2019/2020 class: 17 US students). The INP is actively involved in educating students
from underrepresented groups. Since 2015 20% (2019/2020 = 41%!) of the US/permanent resident
neuroscience students in the program were from these groups. Students are supervised by the Co-Directors,
an executive committee, and through longitudinal mentoring beginning with matriculation. All INP students take
four core graduate classes in neuroscience, quantitative skills and bioethics, two advanced course electives,
and two 1st year research rotations. They attend invited seminars, research in progress talks, an annual retreat
and the Society for Neuroscience meeting at the program’s expense. In the 2nd year the students select a
doctoral adviser from the pool of participating faculty. They also take the doctoral qualifier examination, which
has tutorial, written, and oral components. The students advance to candidacy for the PhD upon defending a
prospectus in the 3rd year. All students are provided travel funds to attend and present their work at national
meetings. A PhD in Neuroscience is awarded to graduates by the INP.

Public health relevance
Project Narrative The INP training program supports the education of the next generation of neuroscience research scientists. INP graduates go on to leading positions in universities, research institutes, and industry, where they contribute to our understanding of the basic principles of the nervous system. Our students and alumni develop rational approaches to understand the outstanding problems in nervous system function, and through their research advance practical solutions for the disorders of the nervous system that afflict society.